iDASH Genome Privacy and Security Competition Workshop

Project Summary
Genomics data sharing is of paramount importance to accelerate biomedical research and facilitate higher power
in analysis. However, privacy and security concerns can hinder large scale data sharing across institutions and
nations. Human genomics data contain unique information that is identifiable, and inappropriate sharing would
put individual’s privacy at risk and potentially lead to leakage of sensitive personal information. Also, patients’
consents are crucial for genomic studies, and therefore novel sociotechnical methods are also essential for
researchers to consider while conducting human genomic research. We intend to close the technology gap and
bring advanced enabling technology to support human genomic research. We have organized a series of
competitions to evaluate state-of-the-art privacy and security models with real-world motivated analysis tasks
with companion workshops. As an emerging interdisciplinary community, we are pushing the frontiers of genomic
privacy and security research. Motivated by our previous successes, we are proposing to continue the effort.
We plan to engage and support researchers from nationally underrepresented groups to participate in our
competitions and attend the workshops.

Public health relevance
Project Narrative We will continue the effort to promote the development of novel yet practical solutions for important privacy and security challenges in human genomic research, via organizing genomic privacy/security competitions and workshops, with emphasis on engaging/supporting researchers from nationally underrepresented groups to participate in our competitions and attend the workshops.